Interrogation of Genetic and Nutritional Control of Sleep across Seasons

ABSTRACT:
Seasonal availability of nutrient constitutes a major driver of organismal physiology that has produced extreme
phenotypes such as hibernation, but also seasonal variation in body weight, blood-glucose control, peripheral
tissue transcription, and sleep in humans. A central theme of these adaptations is the tradeoff between energy
conservation and energy harvesting that drives circannual patterns in feeding and sleeping behavior. The
circadian clock segregates sleep and feeding behaviors to distinct phases of the day in coordination with the
environmental light/dark cycle, yet little is known about how clock regulation of sleep/feeding adapts to seasonal
variation in nutrient and light. My previous postdoctoral research uncovered a phosphorylation event on PER2-
S662 that regulates circadian nutrient sensing and synchronization with seasonal photoperiods. My new
preliminary data reveals sleep, feeding, energetic, and hypothalamic signaling defects in PER2-S662 phospho-
mutant mice that recapitulate seasonal adaptations observed in nature. The overarching goal of this research is
to interrogate the role of the clock in seasonal sleep and feeding adaptations. I hypothesize that light and nutrient
cues that occur during the summer will drive food intake at the expense of sleep by increasing PER2-S662
phosphorylation. Understanding the mechanisms whereby organisms adapt to the seasons is key for gaining
insight into the etiology of disease as humans in modern society are exposed to year-long unhealthy diets and
long photoperiods as a result of modern supermarkets and electronic devices. These cues, therefore, signal a
constant state of summer that is predicted to disrupt sleep and drive development of obesity. The research and
training programs that I have proposed will allow me to establish a novel niche at the intersection of sleep,
circadian rhythms, and seasonality that will fuel a productive independent research program into the future.

Public health relevance
Project Narrative While sleep plays a vital role in human health, the factors that regulate it are not well understood. My preliminary data reveal that dietary nutrient signals the changing of the seasons to the circadian clock, a major sleep regulating process. Here, I will leverage genetic, nutritional, and sleep tools to interrogate the extent to which disruptions in sleep homeostasis create a vicious cycle with overconsumption of calories due to a seasonal adaptation that is encoded by the clock.